Optimizing Cognitive Health in Later Life by Examining Childhood Socioeconomic Status as an Early-Life Risk and Protective Factor Supplement

Project Summary/Abstract Not applicable for this Revision/Supplement.

Public health relevance
Project Narrative Not applicable for this Revision/Supplement.